Building capacity for Implementation Science research in Non-Communicable Diseases (BImS-NCDs)

Abstract
Mbarara University of Science and Technology (MUST) developed and successfully implemented the ‘Mbarara
University Research Training Initiative (MURTI)’ (D43TW010128; PI: Obua) to build capacity for junior faculty in
HIV and non-communicable diseases (NCDs). We now propose to expand on the MURTI investment by creating
a research training hub at MUST with support from National Institutes of Health and IC partners such as the
National Institute of Neurological Disorders and Stroke (NINDS) with the mission is to seek fundamental
knowledge about the brain and nervous system and to use that knowledge to reduce the burden of neurological
disease for all people; the National Institute of Mental Health (NIMH) which supports research that transforms
the understanding and treatment of mental illnesses; and the National Institute on Alcohol Abuse and Alcoholism
(NIAAA) that supports and conducts research on the impact of alcohol use on human health and well-being.
MUST will utilize these supports to strengthen the capacity of rural Uganda health professions training institutions
(HPTIs) on NCDs across the lifespan. NCDs are an emerging global pandemic and the leading cause of death
with disproportionately higher rates in developing countries. MUST, a rural based institution has developed
capacity in NCDs (e.g., neurological disorders, mental health) and IS through the D43TW010128 to address
real-life problems and provide sustainable solutions. We propose a research training hub at MUST for “Building
capacity for Implementation Science research in Non-Communicable Diseases (BImS-NCDs)”. We will draw on
existing expertise (methods and/or infrastructure for mentorship) developed during the D43TW010128 to provide
training and mentoring to clinicians and health professionals, while developing new expertise in IS theories and
frameworks to adapt implementation science tools for the Ugandan context. Through the hub, we will provide
leadership, best practices, research support, mentoring and training in biomedical, behavioral, and IS for long-
term training to the partner institutions in rural Uganda. We plan to address three scientific areas of public
health significance: neurological disorders, mental health, and alcohol use disorders. This will be
achieved through four specific aims: 1) To create a training hub at MUST to support research and research
training in implementation science; 2) To train clinicians and health professionals in basic epidemiological,
prevention, and implementation science skills to conduct research in NCDs across the lifespan in rural Uganda;
3) To provide mentor training for BImS-NCDs mentors; and 4) To create a community of practice among the
trainees and mentors. During the 5-years, we will build capacity of the 6 PhD trainees and over 800 trainees in
short courses. The aims will be supported by expertise from the California University of Science and Medicine
(CUSM), Claremont Graduate University (CGU) and Massachusetts General Hospital (MGH) and within Uganda.
By the end of the 5 Years funding, this grant will have provided foundational expertise for future NCD research
and training focused on rural Africa.

Public health relevance
Narrative Non-Communicable Diseases are an emerging global pandemic with disproportionately higher rates in developing countries. Uganda with a large rural based population, requires development and implementation of evidence-based interventions to address real-life problems and provide sustainable solutions. The proposed Building capacity for Implementation Science research in Non-Communicable Diseases (BImS-NCDs)” training hub at MUST, will provide leadership, best practices, research support, mentoring and training in epidemiological, prevention, and implementation science approaches in NCDs across the lifespan to the partner institutions in rural Uganda.